CORE 1: Data Management and Bioinformatics Core

DATA MANAGEMENT AND BIOINFORMATICS CORE
SUMMARY
The HPMI Data Management and Bioinformatics Core will support the Center's mission in all stages of
research and publication, facilitating reproducible analysis, visualization, and access to center data and results.
The Core will be composed of four major components: software and analysis workflows for data integration
the Cytoscape and the Cytoscape Ecosystem; the Network Data Exchange (NDEx); and the HPMI Data and
Analysis Portal. First, we will develop workflows to integrate proteomics, transcriptomics, genetics, and
functional data generated by Projects 1 and 2 with existing -omics and GWAS datasets to select host factor
candidates for validation. Second, Cytoscape will provide a range of tools for analyzing and visualizing
molecular networks, interaction data, and hierarchical network models from both Projects. The third
component, NDEx, will provide database infrastructure to support the sharing, reviewing, and disseminating of
network data and models. It will also enable consolidated access to public biological network resources for use
by HPMI investigators. Finally, the HPMI Data and Analysis Portal will provide a common access point for
software tools and pipelines and their associated data. The above components – software and analysis
workflows for data integration, visual network maps in Cytoscape, and storage of networks and models in
NDEx – will all be made accessible through the HPMI’s website. Additionally, publications using HPMI products
will be enhanced by the recent additions to Cytoscape for dynamically embedding network data in peer-
reviewed journals. Finally, the Core will draw on an impressive array of hardware infrastructure for
supercomputing, including high performance clusters at multiple sites.